INTEGRATIVE GRAPHICAL MODELS FOR LARGE MULTI-MODAL BIOMEDICAL DATA

? DESCRIPTION (provided by applicant): The new cost-effective high-throughput genomic and imaging technologies have revolutionized the field of clinical diagnosis and research, but they have also created a number of new and significant challenges. The new datasets are large and frequently multi-modal, i.e. the measured variables are of different types: continuous (omics, fMRI measurements), binary (SNPs, gender), numerical (age, drug dosage), categorical (family history of disease, tissue of metastasis), ordinal (tumor stage, smoking). A key analysis aspect is to discover the direct (causal) associations between variables. This is important for many reasons: it can be used for classification, biomarker selection, drug effect, or for mechanistic studies of network perturbations in disease. Graphical models have been used in the past but they are not tuned for (a) multi-modal data and (b) large datasets. The objective of this application is to develop novel methodologies that will identify causal or partially causal networks, which can be used to support and enhance accurate disease prediction, and sub disease classification and help identify key interactions of the molecular mechanisms of diseases. We will develop and test new methodologies based on mixed variable partially causal graphical (MVPCG) models. Evaluation will be done on synthetic and real datasets, including parallel datasets with genomic, genetic and epigenetic data, clinical information and time series diagnostic image data. Our central hypothesis is that an integrative, computational analysis of different modalities of diagnostic patient data can identify complex associations and causal relations between clinical and other disease relevant features and thus help decipher the molecular disease mechanisms. The deliverables will be (1) new graphical approaches for integration and co-analysis of multi-modal biomedical and clinical data; (2) a new, fully documented software package for MatLab and R that can be seamlessly incorporated in other algorithms; (3) a new fully supported graphical user interface (GUI) to further disseminate our methodologies to non computer-savvy users; (4) results on the pathogenesis and predictive features of metastatic melanoma patients; and (5) results on predictive features of autistic spectrum subjects and neurotypicals. If successful, this cross-disciplinary team project will have a positive impact beyond the above deliverables, since the generality of our approaches makes them suitable for studying of any disease and makes them easily integratable into personalized medicine strategies in the future when massive high-throughput data collection will become a routine diagnostic procedure in all hospitals.

Public health relevance
PROJECT NARRATIVE New data collection methods have the potential to revolutionize medicine by generating multiple and informationally complementary data streams from patients. A current roadblock is efficient data analysis of such multi-modal datasets. We propose to use partially causal graphical models to represent the data and identify the direct associations between variables. It is believed that efficient co-analysis of multiple patient data types will improve current disease diagnosis and prognosis procedures, identify subdisease types and help study the disease molecular mechanisms. This project will be performed by a multi-disciplinary team of investigators at University of Pittsburgh and Carnegie Mellon University, including experts in causal modeling, regulatory genomics and clinical care.